Implementation of Digital Mental Health Tools in Ambulatory Care Coordination

Care coordination services have been developed to provide safer and more effective care for patients who
have difficulty managing their healthcare. The role of care managers (CMs) working in care coordination is
intended to take a holistic view of patients and to improve healthcare system efficiency, yet there remain
several gaps in the efficiency of this work. CMs often struggle to find resources for their patients, particularly in
the realm of depression management. Resources are limited, waitlists for services are long, and many patients
are hesitant to seek mental health care. Our research group has developed a productive partnership with the
Ambulatory Care Coordination service at Northwestern Medicine – a large integrated delivery system of more
than 3,500 physicians, serving 1 million patients. Currently CMs, primarily nurses by training, provide remote
coordination services to patients who typically have multiple physical and mental health conditions. They report
abundant challenges in supporting patients with depression. A digital mental health intervention packaged
within a patient management system for depression would fill the need for depression management resources
and fit into CM work. The overarching aim of the proposed project is to adapt and implement a digital mental
health intervention to improve access to and coordination of mental health services in Ambulatory Care
Coordination. Specifically, this study aims to: 1) adapt a digital mental health platform and service model to
address implementation barriers within care coordination, 2) develop and subsequently optimize a
multicomponent implementation strategy, and 3) conduct a randomized rollout effectiveness-implementation
trial of the digital mental health platform and a sustainment pilot period in the 4 regional teams of the
Ambulatory Care Coordination service. Data gathered throughout this project will be used to develop an
implementation guide, capable of being used by other for healthcare systems as they expand their mental
health service offerings to provide holistic support for patients.

Public health relevance
In this study, we will adapt and implement a digital mental health intervention within the care coordination service of a large healthcare system. The intervention will improve access to and coordination of evidence- based mental health services for adults being served in care coordination. Data gathered throughout this project will be used to develop an implementation guide, capable of being used by other for healthcare systems as they expand their mental health service offerings to provide holistic support for patients.